Identifying small molecules with selective toxicity towards muscle invasive prostate cancer cells

This project team aims to screen and develop chemical probes with differential drug sensitivity profiles of a muscle-invasive prostate cancer cell line.

During this period, more than 10,000 compounds from oncology-focused and clinically-approved libraries were screened using cell viability assays to identify chemical probes that lethally and specifically target muscle-invasive prostate cancer cell lines, relative to parental and diverse prostate cancer cell models. Several classes of compounds with distinct mechanisms of action were identified and selected for follow-up studies.